Nathan Shock Centers Coordinating Center

This renewal application seeks to build on the existing Nathan Shock Centers Coordinating Center (NSC3)
infrastructure to further increase and improve the visibility of the Nathan Shock Centers (NSCs), facilitate
collaboration and coordination among the NSCs, enhance NSC training activities, provide support to NSCs to
facilitate compliance with NIH data sharing and clinical research policies, enhanced tracking of pilot grantees
and other activities, and help share resources and facilitate interactions between relevant NIA staff and the
NSCs. The overall goal is to continue and enhance the activities of the NSC3, by maintaining and building on a
system of coordination and communication between the NSCs, NIA, and the biology of aging research
communities that maximizes their respective strengths and supports integrated scientific research approaches
that contribute to our understanding of the biology of aging. We propose innovations across all aims, including
a 2-day NSC annual meeting, robust tracking of pilot applications, career progress, and publications, launch of
collaborative pilot program, career development activities, an Annual Report and more. Because of the
expanded responsibilities, complexity and specific expertise required by the RFA, the current NSC3 will be
reorganized to manage its expanded and multi-faceted mission. The reorganization divides responsibilities to
make lines of responsibility clear, hence maintain effectiveness of the NSC3’s goals. There will now be an
Executive Committee, which, with guidance from a Steering Committee, will provide leadership to the NSC3.
There will also be an Administrative Hub as well as three interacting activity Cores: Data Core, Access, Career
Development and Education Core, and a Communications and Dissemination Core that will implement and
coordinate all NSC aims: 1: Provide logistical support to the NSCs and NIA through an organizational and
management infrastructure that will foster networking, scientific exchange, resource sharing and collaborations
across the NSCs and the field; 2: Grow a diverse workforce in the biology of aging by providing mentoring,
career development, educational support and resources particularly for early career investigators and
investigators new to the field; 3: Disseminate NSC research findings and expand information on resources in
the biology of aging and related fields, and serve as a forum of scientific exchange among NSC investigators
across sites as well as other NIA- and NIH-funded, federal and privately funded initiatives promoting aging
biology training and/or research; 4: Work with the NSCs directors to develop, distribute, and implement a
shared state-of-the art approach and commitment to the renewed NIH emphasis on rigor, reproducibility and
transparency (RRT) in pre-clinical studies by (a) making data and code sharing the norm in basic aging
research; and (b) evaluating the state of science and making best practices more accessible to the community;
and 5: To develop and implement strategies for assessing the effectiveness of the NSCs and NSC3 and use
this information to guide future directions and report outcomes to stakeholders.

Public health relevance
Project Narrative – Nathan Shock Centers Coordinating Center This U24 renewal application seeks to build on the existing Nathan Shock Centers Coordinating Center infrastructure to further increase and improve the visibility of the Nathan Shock Centers nationally and internationally; facilitate collaboration and coordination among the Nathan Shock Centers, enhance Nathan Shock Centers training activities, and help share resources and facilitate interactions between relevant NIA staff and the Nathan Shock Centers. This will contribute to our understanding of the biology of aging, and accelerate innovations that will help us live longer, healthier.